University of Michigan UroEPI Career Development Program

PROJECT SUMMARY This is an administrative supplement to the University of Michigan Urological Epidemiology (UroEPI) Institutional Research Career Development Program (K12) to support the appointment of two additional K12 scholars. The parent K12 program inspires and provides junior investigators/scholars with the necessary technical skills so that he/she can initiate and sustain an independent research program in the study of the epidemiology of benign urological conditions and embrace the interdisciplinarity of our institution. Since the program start in 2016, three scholars have successfully completed the program and progressed to launching their independent careers with notable achievements in publications and grant funding. The UroEPI K12 consists of two principal components: 1) one year of didactic course work with concentrations in epidemiology and biostatistics; and 2) one-two years of applied experience in the conception, execution, and dissemination of a well-designed research project. Guided by their faculty mentor, scholars will be instructed in the philosophy, ethics and theory behind epidemiological research, as well as methodological techniques derived from a broad array of clinical, public health and social sciences. The Director and Co-Director will undertake administration of this program while progress will be monitored continuously by mentors, and biannually by the Mentor Steering Committee (MSC). Scholars will be expected to present their work to the MSC as well as at national scientific conferences. By the end of the training program, scholars will have completed both the requirements for an advanced research degree and a mentored research project, including publication of their findings in the peer-reviewed literature. Graduates of this training program will be well positioned to establish a longitudinal research agenda and to pursue an independent research career in academic Urology with a focus on the epidemiology of benign urological conditions. Encouraging and facilitating the development of academic careers of minority trainees and faculty is an essential mission of the University of Michigan Medical School and the Department of Urology. The Office of Health Equity and Inclusion has a goal of recruiting, retaining, and promoting career development of outstanding faculty, staff, house officers, and students from underrepresented and diverse backgrounds. The UM UroEPI K12 program takes advantage of the resources of the Office of Health Equity and Inclusion in attempting to attract minority candidates for both faculty and fellowship positions. In our continued and enhanced efforts to recruit underrepresented minorities, we have identified two promising applicants. This administrative supplement will support the appointment of these two additional K12 scholars and would help address the under-representation of minorities as well as the disabled in urological science and quality initiatives.

Public health relevance
PROJECT NARRATIVE This administrative supplement to the University of Michigan’s UroEPI program (K12), directed by Drs. Aruna V. Sarma and J. Quentin Clemens will provide rigorous training and career development support for two under- represented minority early-stage investigators seeking to develop the skills necessary to conduct research in benign urology. By increasing the number of well-trained scholars entering the field, we will provide the next generation of physician-scientists with the essential skills to address important clinical and translational epidemiological research questions.